Hair follicle neogenesis in response to wounding

DESCRIPTION (provided by applicant): The long-term goal of this project is to develop better treatments for wounds, alopecias and other degenerative skin disorders by elucidating the cellular and molecular mechanisms of skin regeneration following wounding. We demonstrated that adult mice have the capacity to regenerate hair follicles, sebaceous glands and fat following a full thickness wound. We have evidence that Wnt, Fgf, Hh pathways and gamma/delta T cells are vital players controlling this wound induced hair follicle neogenesis (WIHN). We hypothesize that manipulation of these molecular pathways at the right time and place will convert non-regenerative tissue into regenerative tissue with the ability to form hair follicles, sebaceous glands and fat in response to wounding. To test this hypothesis, we will determine: 1. The role of dermal Wnt/ß-catenin signaling in hair follicle neogenesis using transgenic and conditional knockout mice, 2. The cellular origin of nascent hair follicles in the wound using promoters targeting fibroblasts, myofibroblasts, hair follicle dermal papilla and other dermal subpopulations for lineage analysis, 3. The role of sonic hedgehog signaling in the ability to coax healing wounds to regenerate rather than scar. Human skin xenografted to immunodeficient mice will be studied for its ability to respond with follicular neogenesis to Wnt and/or Shh activation. Ultimately, our findings will yield insights into scarless wound healing tht have implications for understanding skin biology and developing future treatments for wounds, alopecia and other degenerative skin disorders.

Public health relevance
PUBLIC HEALTH RELEVANCE: Scars typically lack hair follicles. We are developing ways to regenerate hair follicles after wounding by taking advantage of genetically manipulated mice that heal with little scarring. These studies will ultimately benefit people with wounds, scars, alopecias and other degenerative skin disorders.